Proof of concept experiments for T3SS inhibitors against burn wound infections

ABSTRACT
The overall goal of this proposal is to develop a novel therapy for the treatment of burn wound infections caused
by the opportunistic Gram-negative pathogen Pseudomonas aeruginosa (Paer), a leading cause of burn wound
infections.Paer colonizes 14 to 33% of burn wounds within 14 days after hospital admission. Paer infections
are difficult to treat due to intrinsic antibiotic resistance, its propensity to adopt the biofilm mode of growth within
burn wounds, and the prevalence of strains that are resistant to several antibiotics. In fact, Paer strains that are
resistant to all anti-pseudomonal antibiotics except the antibiotic of last resort, colistin, have been identified,
prompting the CDC to designate Paer as a “Serious Threat” pathogen. To address the need for innovative
therapies to treat Paer burn wound infections, we propose to evaluate a novel class of small molecules that
inhibit the type 3 secretion system (T3SS), the major virulence factor utilized by Paer to establish infections and
to disseminate in the host. In previous research, we have discovered and chemically optimized the
phenoxyacetamides (PhAs), a series of potent, small molecule inhibitors of the Paer T3SS. As the result of
extensive chemical optimization of this series, we have identified five distinct compounds that are potent
inhibitors of T3SS activity in vitro, are drug-like, and are efficacious as single agents against Paer in an
immunocompetent murine pneumonia model, decreasing bacterial load in the lungs by >1 log10 CFU, and
significantly decreasing dissemination to the liver by >1 log10 CFU. Our strategy for achieving the overall goal
of this proposal is to obtain proof-of-principle data demonstrating that the in vivo validated PhA T3SS inhibitors
are efficacious against Paer burn wound infections using in vitro and in vivo burn wound infection models.
Compounds that meet the milestones for in vivo efficacy will be developed further as novel therapy for burn
wound infections in a follow-on Phase II proposal. To achieve the goal of this proposal, we will complete the
following specific aims: Aim 1. Prioritize in vivo validated T3SS inhibitors using an in vitro burn wound model
(MBX, years 1 and 2); Aim 2. Evaluate 2 prioritized T3SS inhibitors in the murine thermal injury infection model
(MGH, years 1 and 2).

Public health relevance
PROJECT NARRATIVE The opportunistic Gram-negative pathogen Pseudomonas aeruginosa (Paer) is a leading cause of serious burn wound infections that are difficult to treat and frequently lead to sepsis, resulting in a high mortality rate, even when patients are treated with appropriate antibiotics. To address the need for treatments that prevent sepsis, we will evaluate the ability of a novel class of potential drugs that inhibit the type 3 secretion system (T3SS), the major mechanism that Paer uses to establish infections and to spread throughout the host, as a novel treatment for serious burn wound infections. Successful completion of this project will result in 1-2 validated T3SS inhibitors that will be developed further as a novel drug that will be administered with an FDA-approved antibiotic to treat Paer burn wound infections and prevent sepsis.